IMPROVING UNDERSTANDING OF ORAL DISEASE PREVENTION STRATEGIES

Existing national data sets, including 1986 NHIS, 1989 NHIS, 1981 HRSA, National Adolescent Student Health Survey, and current surveys on dental sealants have been analyzed for program planning and publication.